RNA As A Therapeutic Target

DESCRIPTION (provided by applicant): Although 26 years has passed since HIV-1 was identified as the causative agent for AIDS, the percentage of people living with HIV has steadily increased as new infections occur each year and as HIV treatments extend life. An estimated 33 million people were living with HIV in 2007. Most of the current drugs in use for the treatment of AIDS work by combination targeting of the enzymatic activities of the HIV reverse transcriptase and/or protease (HAART, highly active anti-retroviral therapy) and/or gp41. These treatments remain expensive and are often not well- tolerated by patients. Because of the emergence of drug-resistant virus that commonly occurs as the result of classical HIV treatment, there remains a great need to continue the search for alternative therapies that target other essential viral activities. Thus, the development of new drugs with novel mode of action is of utmost urgency. We propose to develop inhibitors of protein-RNA interactions that are absolutely essential for the HIV life cycle-excellent targets widely recognized by the community. TAR and RRE RNAs are well-conserved noncoding sequences in the viral genome with defined targetable structures. Targeting these RNA structures is attractive because the affect virus-specific interactions that could potentially lead to specific inhibition of viral replication, with possibly minimal side effects on other cellular functions. Additionally, this strategy can result in a lower incidence of drug resistance since the regulation of HIV-1 transcription requires the interplay of both viral and cellular components. We have recently reported that branched peptides are good selective ligands for HIV-1 TAR. We propose to carry-out the screening of combinatorial libraries of short branched peptides. This is accomplished with specific aim 1, wherein a larger library of diversified branched peptides and borono-branched peptides is synthesized. Because the major challenge in targeting RNA is imparting selectivity to a particular sequence/structure, a highly stringent screening assay is necessary. This is also addressed in Aim 1. We recognize that during a high throughput screening assay, false positives are possible and that an RNA binder does not necessarily indicate perturbation of the desired protein/RNA interaction. In aim 2, we use a series of cell based assays to test the inhibitory activities of hit branched peptides against HIV-1 Tat/TAR and Rev/RRE interactions. Additionally, we investigate the selectivity as well as possible cytotoxicity of branched peptide inhibitors.

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposed research aims to discover and develop medium-sized molecules that selectively inhibit the interaction of protein-RNA interactions that are absolutely essential for HIV-1 viral replication. If successful, these molecules will be the next generation drugs with novel mode of action as anti-HIV therapy. The proposed research aims to discover and develop medium-sized molecules that selectively inhibit the interaction of protein-RNA interactions that are absolutely essential for HIV-1 viral replication. If successful, these molecules will be the next generation drugs with novel mode of action as anti-HIV therapy. __SpecificAimsTextDelimiter__ A. Specific Aims The long-term goal of this work is to discover and develop molecular entities that can inhibit the functional interaction between HIV-1 protein and RNA elements (Tat-TAR RNA and Rev-RRE RNA) as effective alternative therapy for HIV/AIDS (Figure 1). One forefront of HIV research is the development of novel strategies that do not rely on combination therapy--highly active anti-retroviral therapy (HAART)--because this therapy is expensive, is not well tolerated, and resistance has started to emerge. We propose to develop inhibitors of protein-RNA interactions that are absolutely essential for the HIV life cycle-excellent targets widely recognized by the community. TAR and RRE RNAs are well-conserved noncoding sequences in the viral genome with defined targetable tertiary structures. The challenge in targeting these RNA structures is that it is difficult to find small molecules with the required selectivity, affinity and pharmacological properties to make it to the clinic. Larger, nucleic acid based inhibition such as RNAi or antisense are effective in-vitro but has suffered from stability and, more importantly, poor delivery inside of target cells. Herein, we propose to use medium-sized branched peptides and borono-branched peptides as cell permeable ligands for RNA with the selectivity, affinity and stability required to inhibit Tat-TAR and Rev-RRE interactions. This proposal is innovative because discovering molecules that inhibit HIV protein-RNA interactions can lead to novel therapy as anti-HIV drugs and to novel molecules that can selectively target RNA that are distantly related to antisense and RNAi agents. The scientific impact will be significant because the same class of compounds can be used to target other RNA structures important in biological pathways involved in disease states. Inhibit RNA transcription or RNA function = inhibit viral replication multivalent branched peptide HIV-1 RNA block protein binding site Figure 1. Inhibition of HIV-1 viral replication by targeting conserved tertiary RNA structures with multivalent branched peptides. In the specific aims enumerated below, we expand our library of branched peptides for screening against TAR and RRE RNAs and evaluate the activities of hit compounds using biophysical methods as well as in vitro assays for selective inhibition of TAR and RRE function. Aim 1. To synthesize diversified short branched peptide and borono-branched peptide libraries and screen them against HIV-1 TAR and RRE RNA. We have recently shown that short branched peptides are selective ligands for TAR RNA with good binding affinity because of their capacity to form multivalent interactions; thus a continuation of these efforts is warranted. 1a. To synthesize medium-sized branched peptide libraries of different length 1b. To develop the synthesis of boron-containing amino acid analogs and incorporate them into branched peptide libraries 1c. To develop a more stringent on-bead assay and screen synthesized libraries Aim 2. To evaluate "branched peptide hits" against TAR and RRE RNA using biophysical methods and cell-based assays. Determining the affinity and selectivity of RNA-binding molecules is important to aid in refining RNA ligand properties. 2a. To perform biophysical characterization (Kd measurements, selectivity and binding site determination) of hit branched peptides 2b. To synthesize analogs of the hit compounds and define structure-activity relationships to validate the binding site on TAR and RRE RNA 2c. To determine specificity of inhibition for Tat/TAR and Rev/RRE function using a variety of cell based assays 2d. To assess the ability of the compounds to inhibit replication of HIV-1 and to measure cell cytotoxicity